Administrative/Program Enrichment Core

PROJECT SUMMARY / ABSTRACT ADMINISTRATIVE/PROGRAM ENRICHMENT CORE
All activities of The Jackson Laboratory Nathan Shock Center (JAX NSC), including resource optimization,
quality control, fiscal management, outreach and compliance with institutional, NIH, and NIH policies require
effective management and oversight. The overall goal of the JAX NSC Administrative/Program Enrichment Core
is to provide effective Center administration and enhance the utility of JAX NSC resources across the aging
community. In the current funding period, the Administrative/Program Enrichment Core worked closely with its
External Advisory Board (EAB) to address challenges faced by the JAX NSC, including improving dissemination
of data resources, recruiting dedicated and accomplished faculty, and enhancing and optimizing phenotyping
protocols in our comprehensive cross-sectional and longitudinal mouse studies. In the coming renewal period,
we will build on our current success by providing the research community with even greater access to data,
material resources, and collaborative opportunities by expanding our Pilot Award Program. To achieve these
goals, the Administrative/Programs Enrichment Core will carry out the following specific aims: Aim 1: Support
JAX NSC management and resource coordination through an effective and experienced administrative
structure, weekly staff meetings, bimonthly Aging Interest Group meetings, more efficient tracking and
management systems for mouse resources, and resourceful leveraging of JAX institutional support; Aim 2:
Support JAX NSC External Advisory Board by incorporating improvements recommended by an EAB
consisting of leaders in the aging field; and Aim 3: Enhance NSC visibility nationally by maintaining and
strengthening integration with other NSCs and the NSC Coordinating Center via outreach efforts that
include organizing courses and symposia and establishing a strong web presence. Through the
Administrative/Program Enrichment Core, the JAX NSC will continue to support a robust, effective scientific and
administrative structure that complements that of the larger JAX institutional structure and, importantly, the
overall goals of the NSC program. The two principal investigators who constitute the central administrative
structure have worked closely for many years to successfully manage the JAX NSC and will continue to do so.
The Administrative/Program Enrichment Core will coordinate the activities of all other cores, streamline resource
development and dissemination, centralize and grow the forward-thinking aging program at JAX, offer courses
and symposia highlighting aging research, and support advanced genetic research in aging using novel mouse
models. These activities are critical to the Center's success and effectiveness in meeting its goals and the goals
of the national Nathan Shock Program.